Cancer Biology Research Test-Bed Unit 2: Effects of cell-intrinsic and cell-extrinsic variations in lipid metabolism on metastasis patterns

Project Summary
Metastasis is a highly inefficient process in which few disseminating cancer cells survive. We discovered that
melanoma metastasis is limited by oxidative stress. Reactive Oxygen Species (ROS) increase dramatically in
melanoma cells as they metastasize through the blood. The rare cells that survive undergo reversible
metabolic changes that confer oxidative stress resistance. Consistent with this, large clinical trials found that
patients administered anti-oxidants were more likely to die of cancer than control patients. Cancer cells,
including melanoma, often metastasize regionally through lymphatic vessels before metastasizing systemically
through the blood. We recently discovered that melanoma cells in lymph experience less oxidative stress and
form more metastases than melanoma cells in blood. This was true of patient-derived melanomas growing in
immunocompromised mice as well as mouse melanomas growing in immunocompetent mice. The oxidative
stress kills melanoma cells in the blood by inducing ferroptosis, a form of cell death marked by the
accumulation of lipid peroxides. One of the ways in which lymph protects from ferroptosis is by having high
levels of the monounsaturated fatty acid (MUFA), oleic acid, which protects cells from lipid oxidation by
reducing the abundance of polyunsaturated fatty acids (PUFAs) in membrane phospholipids. The more
abundant PUFAs are in membrane phospholipids, the more sensitive cells are to ferroptosis. Melanoma cells
are thus exposed to different lipid environments in different locations as they metastasize and these cell-
extrinsic changes influence their survival. There are also cell-intrinsic differences among melanomas that
influence their response to these environments: melanomas from different patients differ in the sites to which
they metastasize upon xenografting. We hypothesize that these differences in metastasis patterns result from
cell-intrinsic differences in lipid metabolism that influence their sensitivity to ferroptosis in response to the lipid
environments they encounter as they metastasize. Nonetheless, we have never been able to image the fates
of metastasizing melanoma cells in vivo, limiting our understanding of how oxidative stress affects these cells.
A critical barrier is the efficient imaging of entire organs to identify rare melanoma cells at the earliest stages of
metastasis. The lack of subcellular resolution in whole organs also impairs our ability to explore the ways in
which oxidative stress influences cell survival and proliferation. Both of these limitations will be addressed by
the Technology Development Unit (TDU) of this consortium, which is developing the ability to perform high
throughput imaging of whole, cleared organs to assess the survival, proliferation, and localization of rare
melanoma cells after metastasis. We will validate these imaging data by flow cytometry. By combining single
cell imaging (Aim 1) with metabolic assays, we will characterize cell-extrinsic (Aim 2) and cell-intrinsic (Aims 1,
3) mechanisms that regulate the earliest stages of metastasis.